Sex, HIV, and Air Pollution Effects on Post-TB Lung Disease (SHAPE PTLD)

Abstract
Among the estimated 155 million TB survivors worldwide, a substantial proportion have post-tuberculosis
lung disease (PTLD), characterized by persistent respiratory complaints, abnormal lung function, and/or chest
X-ray abnormalities. Despite its prevalence, PTLD is poorly characterized and poorly understood. Our objectives
are to establish a well-characterized PTLD cohort in a low-income and high-TB/HIV burden country and
determine whether sex, HIV serostatus, and air pollution are associated with distinct lung function-chest CT
PTLD phenotypes. This proposal builds upon a successful 17+ year collaboration in Kampala, Uganda. Our
previous research found significant sex-based and HIV-specific differences in spirometry post-pneumonia, and
preliminary data indicate similar trends in spirometry, total lung capacity (TLC), and diffusing capacity for carbon
monoxide (DLco) post-TB. Specifically, post-TB women with HIV exhibited stronger trends towards abnormal
spirometry, TLC, and DLco compared to post-TB men with HIV; this was not seen in post-TB persons without
HIV or in persons without TB. Post-TB women with HIV also had significantly higher PM2.5 levels than their male
counterparts. These findings support our central hypothesis that there are sex-based and HIV-specific
differences in the lung function-chest CT presentations of PTLD and that women with HIV are at increased risk.
We hypothesize that these sex and HIV differences are exacerbated by higher PM2.5 levels in women and an
enhanced deleterious effect of PM2.5 exposure in HIV. To address this, we will enroll 650 post-TB and 165 non-
TB adults. We will determine the impact of sex and HIV on lung function-CT findings and investigate whether
sex or HIV modifies the associations between PM2.5 and PTLD. Aim 1: Determine the impact of sex and HIV on
spirometry, TLC, and DLco in persons with and without TB at baseline (end of TB treatment for TB) and follow-
up (2 years later). Hypothesis: Post-TB women with HIV will have higher odds of abnormal lung function than
post-TB men with HIV; no such sex difference will be found in post-TB persons without HIV (primary hypothesis)
or those without TB (secondary). Aim 2: Determine the impact of sex and HIV on CT findings using conventional
chest radiologist interpretation and novel, automated AI algorithms in persons with and without TB at baseline
and follow-up. Hypothesis: Post-TB women with HIV will have higher odds of emphysema, fibrosis, small airways
disease, and vascular abnormalities on CT than post-TB men with HIV; no such sex difference will be found in
post-TB persons without HIV or those without TB. Aim 3: Determine whether sex or HIV are effect modifiers of
the relationship between PM2.5 and lung function-CT findings using short- and long-term PM2.5 measurements
from personal samplers and residential satellite-based spatiotemporal models. Hypothesis: The relationships
between PM2.5 and PTLD findings will be more pronounced among women compared to men and among persons
with HIV compared to persons without HIV. This research will serve as a foundational study of PTLD, leading to
advancements in its diagnosis and management, mechanistic studies, and targeted interventions in the future.

Public health relevance
Narrative Many individuals who recover from tuberculosis (TB) continue to experience respiratory symptoms, frequently accompanied by abnormalities detected in pulmonary function tests and chest radiographs. This highlights the need to better understand this condition, which is referred to as post-tuberculosis lung disease (PTLD). This project will perform a comprehensive series of tests to assess the frequency and severity of PTLD, explore whether certain populations, specifically women and those infected with human immunodeficiency virus (HIV), are more susceptible to PTLD, and if so, examine potential underlying causes, such as exposure to air pollution.